Radiomics for Clinically-Acquired Brain MRIs of Youth with Neurodevelopmental Disorders

PROJECT ABSTRACT
The millions of brain MRIs acquired each year in clinical settings are a vastly underutilized scientific resource.
Meanwhile, brain MRIs collected in research studies often struggle to recruit cohorts fully representative of
populations of interest, particularly in the case of rare neurodevelopmental disorders. One clear opportunity for
discovery science are pediatric MRIs where gross pathology has been ruled out in children with headache,
concern for head trauma, or neurodevelopmental symptoms such as delayed milestones, autism, or psychosis.
One reason why brain morphology phenotypes derived from clinical brain MRIs have been underutilized is due
to the expected technical differences across sites and scanners, which pose methodological and statistical
challenges. However, our study team recently developed brain growth charts based on one of the largest
aggregated neuroimaging datasets to date, which provide an unprecedented model for brain MRI
developmental imaging phenotypes -- including quantitative measures of brain volumes of cortical and
subcortical brain regions – to be accurately benchmarked against population norms while controlling for
technical differences. In preliminary investigations, we have now further developed this approach to benchmark
individual patients' brain anatomy against hospital norms – so-called “clinical controls” – to provide high-quality
imaging metrics to combine with data on genetics, environmental exposures, and neuropsychiatric outcomes.
Using advanced, fully-reproducible image processing, deep learning, and statistical modelling, we will develop
a clinical radiomics reference that allows precise quantification of where an individual clinically-acquired brain
MRI lies in reference to expected developmental variation, using 20,000 clinical MRIs without gross pathology
obtained by Children's Hospital of Philadelphia care teams (Aim 1). By integrating records of clinical MRIs with
large-scale CHOP biobanks, we will identify developmental imaging phenotypes associated with high genetic
risk for neuropsychiatric and neurodevelopmental disorders (Aim 2). By integrating secondary analysis of
clinically-acquired scans with prospective behavioral phenotyping and neuroimaging, we will identify
developmental imaging phenotypes associated with psychiatric vulnerability in individual patients (Aim 3).
Throughout, we will generate practically useful brain chart resources that will facilitate analysis of clinically-
acquired brain scans by other researchers (Aim 4). By leveraging clinically-acquired brain MRIs, this proposal
harnesses untapped neurogenomic information to investigate neurodevelopment trajectories in high-risk youth,
capitalizing on the PI and assembled team's expertise in psychiatric and developmental brain imaging,
imaging-genetics and neuroinformatics. The project will provide the necessary infrastructure to support future
HIPAA-compliant multi-site collaborative projects across health systems with expected sample sizes on the
order of millions of scans.

Public health relevance
PROJECT NARRATIVE In hampered acquired will features used contrast to rain magnetic resonance images acquired in research settings, technical obstacles have to date our ability to extract valuable quantitative information from the vast amounts of brain imaging data in clinical pediatric settings. Leveraging a recently validated computational approach, this proposal generate brain growth chart models that allow accurate, quantitative benchmarking of brain morphological from clinically-acquired brain scans. Newly extracted i nformation from clinically-acquired scans will be to identify brain neuroanatomical profiles associated with b high genetic risk for neurodevelopmental disorders and behavioral health outcomes.